Metabolomic Signatures of Alcohol Consumption and Risk of Knee Osteoarthritis

PROJECT SUMMARY / ABSTRACT
Osteoarthritis (OA) is the most prevalent joint disease and a leading cause of chronic pain and disability, affecting
approximately 32.5 million Americans. In the absence of disease-modifying therapy, there is an urgent need for effective,
widely available approaches to aid in the prevention and management of this common condition. As an important lifestyle
factor, alcohol use has been associated with over 60 acute and chronic health conditions controversially. Previous studies
have examined the cross-sectional association of alcohol consumption with the prevalence of knee OA, but the evidence
from well-designed cohort studies or randomized clinical trials remains limited. Recently, using the data from
Osteoarthritis Initiative (OAI), a multi-center prospective cohort study of knee OA, we observed a prospective association
between excessive alcohol intake and a higher risk of knee OA. However, self-report alcohol assessment methods may be
subject to recall bias and measurement error. Inaccurate measurement of alcohol exposure may make it difficult to detect
moderate associations with disease risk. Biomarkers of alcohol intake taking into account the bioavailability and
metabolism may better represent long-term exposures. Recently, metabolomics, by measuring a large number of
downstream components (metabolites), provides the most integrated profile of biological status reflecting environmental
and genetic interactions, and therefore may more precisely define alcohol and dietary exposures and provide better
estimates of disease risk in epidemiologic studies. To date, intervention studies have identified a variety of metabolites
related to alcohol consumption, and 15 of them have been well-validated by multiple studies. However, no study has
ever assessed the association between alcohol-related metabolites and the future risk of knee OA. Using the existing
data from a well-defined case-cohort study including 603 participants (237 incident knee OA cases and 366 non-cases) in
the OAI cohort, we propose to examine whether individual metabolites related to alcohol intake predict the subsequent
incidence of radiographic and symptomatic knee OA. Additionally, we will derive a composite score to measure the
metabolomic signature of overall alcohol consumption accounting for the relative importance of individual metabolites
and examine the association with the knee OA risk. An external sample from the Multicenter Osteoarthritis Study
(MOST) will be used to validate the findings. Then we will examine whether alcohol-related metabolites and the
metabolomic score influence imaging markers of knee OA (e.g. cartilage damage, bone marrow lesion, effusion). Finally,
we will examine whether imaging markers of knee OA mediate the associations of alcohol-related metabolites and the
composite score with the risk of knee OA. Using advanced metabolomic techniques, this
innovative study
will examine
whether alcohol consumption is a modifiable risk factor for knee OA and offer the potential to identify OA prevention
strategies, therefore it will have large potential public health implications. In addition, this study will provide preliminary
data for future R01 grants to examine the underlying biological pathways in a multi-omics study (such as genomics,
metabolomics, proteomics, etc.).

Public health relevance
PROJECT NARRATIVE The proposed project will assess whether metabolomic signatures of alcohol intake predict the subsequent risk of knee OA, and examine how these signatures influence imaging markers of knee OA. Finally, we will investigate whether the imaging markers mediate the associations between metabolomic signatures of alcohol intake and the risk of knee OA.